Physiological mechanisms underlying disrupted hippocampal function in Fragile X syndrome

Project Summary/Abstract. Fragile X syndrome (FX) is a widespread type of inherited intellectual disability.
Effective treatments that target mechanisms underlying FX are currently lacking. FX is the foremost monogenic
cause of autism spectrum disorders, and thus many individuals with FX exhibit abnormal social behaviors.
Individuals with FX also often engage in aberrant spatial behaviors such as “elopement”, wandering off and
getting lost. The hippocampus is a brain structure that is particularly vulnerable to FX. Much evidence suggests
that hippocampal areas CA2 and CA1 are important for social behaviors and spatial memory, respectively. Yet,
few studies have investigated whether disturbances in neurophysiological mechanisms of social and spatial
memory functions in CA2 and CA1 underlie social behavioral and spatial memory impairments in FX. This
project’s goal is to address this gap in knowledge by investigating the extent to which subcellular, cellular, circuit,
and network mechanisms of social and spatial memory operations in the hippocampus are impaired in rodent
models of FX. The studies will employ state-of-the-art in vivo and in vitro electrophysiological techniques. In vivo
approaches will be used to assess whether aberrant cellular and network mechanisms are related to deficits in
social exploration and spatial memory. In vitro experiments will uncover cellular mechanisms underlying altered
intrinsic properties and plasticity in CA2 and aberrant inhibition in CA1. Models of FX in two species, specifically
Fmr1 knockout (KO) rats and mice, will be used, allowing comparison of FX pathophysiology across species.
Specific Aim 1 will assess whether the strength of inputs to CA2 neurons during exploration of social stimuli is
weaker in Fmr1 KO rats than wildtype rats. This Aim will also use sophisticated behavioral tracking software to
determine whether Fmr1 KO rats show aberrant behavioral patterns during social exploration. Specific Aim 2 will
employ whole cell and patch clamp recordings, including recordings directly from dendrites, in hippocampal
slices to test whether CA2 neurons in Fmr1 KO rats and mice show impaired synaptic plasticity and responses
to the social neuropeptide, oxytocin. Specific Aim 3 will test whether coordination of spike sequences from
ensembles of CA1 neurons, believed to be an important network mechanism of spatial memory processing, is
disrupted in Fmr1 KO rats performing spatial memory tasks. Coordination of spiking across ensembles of
hippocampal neurons requires properly timed activation of specific CA1 interneurons. Thus, disrupted
coordination of CA1 spike sequences in FX may reflect disturbances in CA1 interneurons. Specific Aim 4 will
employ whole cell recordings of specific classes of CA1 interneurons and inhibitory inputs to CA1 pyramidal cells
to test the hypothesis that inhibitory circuits are disrupted in FX. Successful completion of these Aims will provide
novel insights about specific mechanisms underlying aberrant social and spatial behaviors in FX. Gaining a
deeper understanding of FX mechanisms is expected to suggest novel targets for intervention in FX.

Public health relevance
Project Narrative. Fragile X syndrome (FX) is associated with deficits in social and spatial behaviors, yet the neural mechanisms responsible for these impairments remain poorly understood. Hippocampal areas CA2 and CA1 are key brain regions for sociality and spatial memory, respectively. In this project, we aim to uncover neurophysiological disturbances in CA2 and CA1 that underlie social and spatial memory impairments in FX and may point toward new symptom-specific treatment targets.